Chemistry Discipline B Track 3 Animal Food Testing

Project Summary: The Michigan Department of Agriculture and Rural Development (MDARD) Food, Fuel, and Disease section intends to use this funding opportunity to improve the section's animal food testing surveillance programs, building a more robust and efficient program. The section intends to continue resting commodities for its current spectrum of testing: mycotoxins; Aflatoxin B1, Aflatoxin B2, Aflatoxin G1, Aflatoxin G2, Deoxynivalenol, Fumonisin B1, Fumonisin B2, Fumonisin B3, Ochratoxin A, and Zearalenone, veterinary drugs; Amprolium, Carbadox, Chlortetracycline, Decoquinate, Lasalocid, Monensin, Oxytetracycline, Ractopamine, Sulfamethazine, Sulfadimethozine, Sulfaquinozaline, Tilmicosin, and Tylosin, nutrient and heavy metals; Aluminum, Antimony, Arsenic, Barium, Boron, Cadmium, Calcium, Chromium, Cobalt, Copper, Lead, Magnesium, Manganese, Molybdenum, Phosphorus, Potassium, Selenium, Sodium, Sulfur, and Zinc crude fat content, crude fiber content, and protein (Nitrogen) content but plans to also begin to expand sample volume and testing methodologies, such as adding CBD/THC testing of pet foods. The section also plans to work on building an increase collaboration between interdepartmental agencies and the FDA.

Public health relevance
Project Narrative: With agriculture being on of Michigan greatest economic drivers the need to protect the animal feed integrity is of the utmost importance. The Michigan Department of Agriculture and Rural Development (MDARD) Food, Fuel, and Disease section intends to use this funding opportunity to improve the section's animal food testing surveillance programs, building a more robust and efficient animal feed testing program to test for mycotoxins; Aflatoxin B1, Aflatoxin B2, Aflatoxin G1, Aflatoxin G2, Deoxynivalenol, Fumonisin B1, Fumonisin B2, Fumonisin B3, Ochratoxin A, and Zearalenone, veterinary drugs; Amprolium, Carbadox, Chlortetracycline, Decoquinate, Lasalocid, Monensin, Oxytetracycline, Ractopamine, Sulfamethazine, Sulfadimethozine, Sulfaquinozaline, Tilmicosin, and Tylosin, nutrient and heavy metals; Aluminum, Antimony, Arsenic, Barium, Boron, Cadmium, Calcium, Chromium, Cobalt, Copper, Lead, Magnesium, Manganese, Molybdenum, Phosphorus, Potassium, Selenium, Sodium, Sulfur, and Zinc crude fat content, crude fiber content, and protein (Nitrogen) content.